The Role of MicroRNA 181b in the Development of Vascular Stiffness with Age

PROJECT SUMMARY
Candidate: Eric Tuday, MD, PhD is an assistant professor with a dual appointment to the Division of
Cardiology at the University of Utah and the Translational Physiology Laboratory at Salt Lake City VA. Dr.
Tuday's research is focused on the impact of miR-181b expression on the development of age-related large
artery stiffness. Dr. Tuday's long-term goal is to independently direct an extramurally funded laboratory with
research focused on the vascular biology of aging and addressing age-related vascular diseases.
Career Development: This award will support Dr. Tuday's career development by building on his existing
training in cardiovascular physiology. Specifically, Dr. Tuday will receive extensive training in the planning and
execution of studies assessing whole vessel and individual smooth muscle health in rodents. The career
development plan outlines a coordinated effort to train the candidate in areas including: vascular biology of
aging; assessment of molecular pathways pertinent to pathologic states, animal genetic models, and state of
the art cellular interrogation methods; didactic course work designed to facilitate a better understanding of
fundamentals of therapeutic product development, animal research, and biostatistics; and, regular attendance
at vascular aging, genetics, and molecular biology conferences; and lastly exposure to teaching.
Environment: The University of Utah is an ideal environment for Dr. Tuday's career development. This
environment provides all the resources needed to complete the proposed studies during this K08 proposal.
The University of Utah also provides a rich environment for formal and informal training in career development.
Research: The central hypothesis of this research project is that age-related reductions in microRNA-181b
expression levels results in the deregulation of pro-inflammatory pathways that ultimately result in increased
large artery stiffness. It is known that microRNA-181b is beneficial in terms of vascular health and that levels
decrease with age; we seek to understand these mechanisms. While many of the mechanisms of microRNA-
181b have been described, we contend that there are unstudied pathways influenced by microRNA-181b of
significance as they relate to vascular health, specifically to vascular smooth muscle cells (VSMC). Finally, we
hypothesize that chronic, VSMC specific, microRNA-181b overexpression can prevent the age-associated
increases in large artery stiffness that ultimately preserve cardiovascular health.

Public health relevance
PROJECT NARRATIVE microRNA-181b is highly expressed in the vasculature, and has overall, been shown to be beneficial in terms of vascular health. Studies examining the role of microRNA-181b in the vasculature has shown that microRNA- 181b decreases with age with a concurrent rise in vascular stiffness and that induced vascular stiffening has been prevented by increasing levels of microRNA-181b. The purpose of this proposal is to determine the exact mechanism(s) of the age-associated decline in microRNA-181b, discover the unknown downstream targets of microRNA-181b, and measure the effect of microRNA-181b overexpression on vascular health with aging.